Data Management and Biostatistics Core

Data Management and Biostatistics Core
SUMMARY
The primary objectives of the Data Management and Biostatistics Core (DMBC) are to establish a
centralized data management system for both laboratory and field data from research projects within
the ICEMR, provide statistical assistance and training to ICEMR consortium members, and improve
biostatistical capacity for malaria research and control in Ethiopia. To achieve these objectives, the
DMBC will aid investigators with tasks such as creating data dictionaries, designing data entry forms,
and ensuring data quality using standard operating procedures and quality control checks. Our previous
ICEMR has provided the DMBC with profound experiences in managing multi-layered data, including
remote sensing data, ecological and geospatial features, population genomics data, and clinical
information generated through the proposed projects. The DMBC will utilize a cloud-based data
management system developed from the previous ICEMR, which will be upgraded and customized to
suit the new project's requirements. Emphasis will be placed on the use of standardized terminology
and electronic data capture, monitoring of data quality, establishing a comprehensive sample tracking
system, enhancing data security, and facilitating data sharing in accordance with NIH guidelines. The
DMBC will play a critical role in managing the different types of datasets collected by the ICEMR
projects and in implementing the data management and sharing plan. The specific aims of the DMBC
are: 1) establish a standardized data acquisition and management system for all ICEMR activities; 2)
provide statistical support and training to ICEMR members; and 3) develop and implement scientific
data sharing plan. The DMBC will be under the direction of Dr. Ming-Chieh Lee at UCI and supported
by biostatisticians and data managers in both the United States and Ethiopia.

Public health relevance
Public Health Relevance The Data Management and Biostatistics Core will provide centralized data management for the two research projects of this ICEMR to enable timely data sharing, analysis and biostatistical support. The Core will provide training to students and scientists to enhance statistical and data management capacity in Ethiopia.